Investigating the microbiome in persons living with HIV

We have a collaboration to clinically evaluate and collect biospecimens from persons living with HIV. In a longitudinal manner, we have collected biospecimens from individuals prior to the initiation of antiretroviral therapy as well as individuals on antiretroviral therapy. We have performed microbiome sequencing of biospecimens and are analyzing data from individuals who have initiated antiretroviral therapy in order to monitor the human microbiome as the immune system is restored and as viral load is controlled.